Combined Experimental and Analytical Study of the Effects of Zone V Extensor Tendon Injuries on Hand Function

Extensor tendon injuries of the hand are common and potentially debilitating. The long-term objective of
this research is to improve patient outcomes following extensor tendon injury. The first step towards this
objective is to determine the effect of extensor tendon injury on patient function. Additional steps can then be
taken to improve treatment and outcomes once the underlying causes of poor patient outcomes are known. The
first step is the focus of this proposed work.
Cadaveric experiments and mathematical modeling will be used to increase our understanding of the effect
of extensor tendon injuries on hand function, and to improve treatments for extensor tendon injuries.
In the cadaveric experiments the extensor tendons will be loaded to generate finger motion. Tendon
excursion, tendon load, grip and finger rotation will be measured during these experiments. There will be two
experimental groups with different patterns of extensor injury. Data collected from the first experimental
group will be used to create mathematical models relating extensor tendon injury to finger function. The
mathematical models will take simulated injury as an input and output finger motion and grip strength. An
optimization procedure will be used to generate the models. Given the extensor tendon injury configuration in
group one, the optimization will adjust the mathematical model parameters to minimize the difference between
model output and group one data.
These optimized mathematical models will then be given group two injury configurations as a system input.
The accuracy of the mathematical models will be determined by comparing the model’s outputs to data
collected from the second experimental group.
The effect of extensor tendon injury on finger function will be determined using repeated measures analysis
of variance. Accuracy of the mathematical models will be quantified using a similarity metric comparing the
second group’s experimental data to the output of the mathematical models using group two’s set of simulated
extensor injury.

Public health relevance
Extensor tendon injuries of the hand are more common than anterior cruciate ligament injuries. Outcomes after treatment vary, with some patient reported outcomes reporting the same quality of life as two and five finger amputees. The goal of this research is to understand the causes of the functional deficits with a view towards improving patient outcomes following extensor tendon injury.